New York Regional Center for Diabetes Translation Research

The Administrative (ADM) Core of the New York Regional Center for Diabetes Translation Research (NY- CDTR) provides the fundamental infrastructure necessary to strengthen such research at the Albert Einstein College of Medicine with Montefiore Health Systems, and other partnering institutions of our Core faculty and members to stimulate the next generation of diabetes translation research through the following aims: 1) To provide dynamic and responsive leadership. The ADM will afford consistent scientific leadership to articulate and implement a clear vision for the translational research direction of the Center. The Program Director, Jeffrey Gonzalez, PhD, will provide strong and responsive leadership to accelerate translational research on diabetes and obesity that contributes to public health improvements in diabetes outcomes. 2) To provide robust infrastructure for the maintenance of four cutting edge Translational Research Cores. We have developed and refined four Translational Research Cores furnishing the infrastructural bedrock of the NY-CDTR: Behavioral Science and Technology Core; Life Course Methodology Core; Population Health and Health Systems Core; and the Psychosocial Research on Intervention Science and Mechanisms of Disease in Diabetes” (PRISM-D): A National Resource Core. 3) To administer vibrant Center Programs, including an Enrichment Program and a Pilot and Feasibility (P&F) Grant Program. The ADM will leverage the many resources of our collaborating academic institutions, funded Centers and CTSAs, so that the Enrichment Program activities are accessible for members as well as potential new members; there is also a heightened awareness of the wealth of educational programs for diabetes translational investigators focused on research to improve health outcomes across communities. The ADM will also provide infrastructure and support for the robust, mentored P&F Program to fund promising research proposals from early-stage investigator members. Maintenance of a useful and up-to-date NY-CDTR website will make these resources accessible to our members and non-members across the country. We will also stimulate and promote use of supplemental funding opportunities throughout our national network. 4) To objectively evaluate progress, facilitate efficiency, and ensure ethical conduct of research, and quality control, with guidance from multi-stakeholder and community-based advisors. The ADM institutes a system of reportage and evaluation to ensure that services meet expectations; initiatives continue to be effective; progress is reported in a timely and comprehensive manner; and established objectives continue to be met. The ADM will work with an Internal Advisory Committee and External Scientific Advisory Committee to ensure the cost efficient and high impact performance of all Center activities to guide the evolution of the NY- CDTR toward the next generation of diabetes translation research that is responsive to community